Experimental Manipulation of the Emotional Salience of Cannabis Use-Related Information

PROJECT SUMMARY
Given the rising prevalence of daily cannabis use, the tremendous public health burden of Cannabis Use
Disorder (CUD), and the low treatment-seeking rates in people with CUD, it is becoming increasingly important
to understand the mechanisms through which disordered use is maintained and recovery is thwarted.
Recognizing and giving credence to the negative consequences of chronic drug use is a vital prerequisite for
behavior change. Emerging evidence suggests that the closely connected medial orbitofrontal cortex (mOFC)
and rostral anterior cingulate cortex (rACC) are key neurobiological substrates involved in these processes. A
neural measure related to mOFC activity, along with mOFC itself, have been implicated in the processing of
self-referential substance use-related statements. Further, altered OFC and rACC connectivity was associated
with denial of substance-related problems, while rACC activation was inversely correlated with perceived need
to change substance use. Additionally, a neural signal related to ACC activity was altered in individuals with
severe CUD who had reduced self-awareness of their behavior during a drug choice task. Altogether, these
studies point to aberrant mOFC/rACC activity and connectivity, though the studies have been limited by their
low prevalence and correlational nature, suggesting the need for causal testing of mOFC/rACC’s involvement
in these important processes. Theta burst stimulation (TBS), a type of repetitive transcranial magnetic
stimulation (rTMS), is a safe and effective option for acute noninvasive causal manipulation of neural activity
that has successfully induced neural and behavioral effects after a single session of stimulation. The proposed
project was conceptualized and designed to provide training in TMS methodology, magnetic resonance
imaging (MRI) and functional MRI (fMRI) methodologies, and experimental task development pertaining to
addiction insight theory to the applicant, along with further professional development that will help accelerate
his career goals as an independent clinical scientist. Approximately 34 individuals with severe CUD recruited to
the proposed study will be randomized to receive either continuous TBS (cTBS) or intermittent TBS (iTBS),
along with sham TBS. Specific Aim 1 involves localizing the effects of TBS in terms of changes to cerebral
blood flow to mOFC or other areas engaged through the TBS manipulation. Specific Aim 2 will test mOFC as a
neural mechanism involved in cannabis use problem recognition using an improved version of our previously
validated Auditory Self-Referential Processing Task. Finally, Specific Aim 3 will determine if mOFC modulation
affects behavioral choice insight in drug choice contexts during our previously validated Probabilistic Choice
Task. The results from this novel and rigorous project will provide critical knowledge of the neurobiological
mechanisms underlying the processing of drug use-related self-referential information, which could inform
future interventions to improve insight into substance use disorders and other maladaptive behaviors and
increase treatment-seeking rates for a debilitating set of disorders.

Public health relevance
Project Narrative With rising daily cannabis use, Cannabis Use Disorder is becoming increasingly prevalent in the United States and is associated with significant disability, though most people with Cannabis Use Disorder do not seek treatment. Recognizing and emotionally engaging with negative consequences of chronic drug use is considered an important step toward change and have been linked to the medial orbitofrontal cortex and rostral anterior cingulate cortex, two closely connected areas of the brain. Using theta burst stimulation, this study will experimentally manipulate activity at the medial orbitofrontal cortex to test whether emotional engagement with cannabis-related problem statements and downstream behavioral self-monitoring in drug choice contexts may be mechanistically linked to the medial orbitofrontal cortex.